REDUCTION OF RADIATION INDUCED CELL CYCLE ARREST BY AMILORIDE

Flow cytometry were used to investigate the effects of amiloride on cell cycle progression, and the effectiveness of amiloride to attenuate the S and G2 phase checkpoint responses induced by 2.5, 5.0 and 7.5 Gy of gamma radiation. The late S phase delay and the radiation-induced G2 block were both significantly reduced in amiloride-treated samples without apparent apoptosis or necrosis over a 24 h period. Results indicate that amiloride reduces the radiation-induced G2 block in HL-60 cell populations almost equally well as caffeine, and to a greater extent than staurosporine. Alterations in intracellular ion concentrations induced by amiloride may lead to changes in Ca2+-dependent signaling cascades, and thereby decrease the radiation-mediated cell cycle perturbations.